Malaria associated pathogenesis of chronic kidney disease (MAP-CKD)

PROJECT SUMMARY/ABSTRACT
Acute kidney injury (AKI) is an abrupt loss of kidney function that occurs in 25-59% of children hospitalized with
severe malaria. AKI is one of the strongest risk factors for death in children with severe malaria and is associated
with long-term cognitive and kidney problems. Following injury, the kidney undergoes a repair process to restore
normal kidney function. If the repair process goes awry and is ‘maladaptive’, it can lead to persistent kidney injury
and chronic kidney disease (CKD). Our previous studies showed an increased risk of CKD in severe malaria
survivors. These results led to our central hypothesis that persistent activation of pathways associated with
severe malaria associated-AKI contributes to maladaptive repair following AKI and increases CKD risk. Towards
this hypothesis, we have preliminary data showing that persistent immune activation and signs of altered blood
vessel function are associated with persistent kidney disease at one-month follow-up. An estimated 15.6% of
Ugandan children have persistent kidney injury after severe malaria with 17.5% of children with persistent kidney
injury dying within one-year follow-up compared to 3.7% without AKI. Guided by strong preliminary data, we
propose a prospective multi-site observational cohort study to follow 750 Ugandan children, 90 days to 15 years
of age, hospitalized with severe malaria to assess the incidence of CKD. We will also enroll 189 community
children of the same age to define the incidence of CKD in Ugandan children. We will pursue two Specific Aims
to evaluate the malaria-associated pathogenesis of acute and chronic kidney disease (MAP-CKD) after severe
malaria. In Aim 1, we will determine clinical risk factors associated with CKD, including the severity and duration
of AKI as well as a poorly understood complication of malaria called blackwater fever. We will also evaluate the
genetic risk factors for CKD in children over follow-up, focusing on genes linked to kidney disease (e.g., APOL1)
or protection from severe malaria (e.g., sickle cell anemia). In Aim 2, we will focus on defining mechanisms of
maladaptive repair following AKI by measuring biomarkers in children’s blood and urine over follow-up. These
studies will have the potential to uncover pathways of maladaptive repair following AKI that lead to the
development of CKD and are amenable to intervention. Our long-term goal is to prevent children from developing
CKD. These studies will achieve this goal by allowing us to identify children at the highest risk of CKD, providing
clinical follow-up and early treatment for CKD. Secondly, by determining the maladaptive nature of the healing
process, we will be able to use biomarkers to identify children at risk of CKD. Third, these studies have the
potential to identify treatments to promote adaptive renal repair and reduce CKD development. Collectively, our
proposed research will provide new insights into kidney disease in malaria and may provide novel insights into
mechanisms of maladaptive repair in other conditions characterized by intravascular hemolysis and AKI. The
results from this study will help define the burden of CKD following AKI in low-and-middle-income countries,
where 80% of global AKI deaths occur.

Public health relevance
PROJECT NARRATIVE Our proposed study in Ugandan children aims to understand how some children with severe malaria experience an abrupt loss of kidney function while sick and do not recover normal kidney function. Poor kidney health places children at higher risk of repeated kidney injury and poor health, leading to repeated hospitalizations. This study may identify medicines that can help kidneys recover from injury and lead to improved long-term recovery and health.